Structural and Biochemical Studies of Blood Coagulation Factor VIII to Overcome the Immune Response

Summary
Blood coagulation factor VIII is a protein cofactor that is essential for the proper regulation of the clotting
cascade. Deficiencies in factor VIII cause hemophilia A, the most common severe genetic bleeding
disorder, affecting 1 in 5,000 males worldwide. Treatment for hemophilia A consists of therapeutic infusions
of a functional form of factor VIII, termed “replacement therapy.” Complications to factor VIII replacement
therapy consist of an inhibitory immune response to the infusion in 25-30% of hemophilia patients receiving
treatment. Moreover, autoimmune disorders arise in healthy individuals against native factor VIII, causing
acquired hemophilia A. As factor VIII has been repeatedly described as highly immunogenic,
understanding the structural nature of this immune response, how activated factor VIII (fVIIIa) binds
activated platelet surfaces, and how fVIII forms a membrane-bound procoagulant complex with fIXa, may
lead to more effective therapies for hemophilia A patients.
In our previous studies, we have: developed and tested a working model of membrane binding by the C-
terminal (C2) domain of factor VIII through multiple assays, determined the first high resolution structure
of B domain-deleted factor VIII, and structurally characterized antibody inhibitors that target the factor VIII
C1 and C2 domains, which have resulted in further understanding of the pathogenic anti-factor VIII immune
response. To further examine the structural nature of factor VIII protein complexes that exist in circulation,
this proposal will accomplish three specific aims. First, we will examine the structural and thermodynamic
basis of activated platelet binding by: determining the X-ray crystal structure of an activated form of
bioengineered fVIIIa; measuring the membrane binding thermodynamics of isolated C1 and C2 domains,
as well as a tandem C1-C2 domain construct with isothermal titration calorimetry (ITC); and characterizing
the structural and dynamic nature of C2 domain membrane binding in residue-level detail with small lipid
nanodiscs with 2D 15N/1H NMR spectroscopy (Specific Aim 1). Second, we will elucidate the molecular
basis for the lipid membrane-associated intrinsic tenase complex between fVIIIa and fIXa bound stably to
small lipid nanodiscs (Specific Aim 2). Third, we will continue to characterize the immune response to
factor VIII replacement therapy by determining high resolution cryoEM and/or X-ray structures of B domain-
deleted factor VIII in complex with (1) anti-A2 domain inhibitory antibodies, and (2) hemophilia A patient-
derived inhibitory antibodies (Specific Aim 3). By examining the factor VIII immune response at atomic
resolution, paired with structural characterization of factor VIII circulatory complexes, our results will
illustrate in detail the life cycle of factor VIII and its procoagulant activity. The structural data that result
from this study will assist in the engineering and development of next generation therapeutics to better
treat hemophilia A patients worldwide.

Public health relevance
Project Narrative Hemophilia A is caused by the disruption of the gene encoding blood coagulation factor VIII and is the most common form of hemophilia, affecting 1 in 5,000 males worldwide. The most significant complication in the management of hemophilia A is the development of an inhibitory immune response to therapeutically infused factor VIII. Studying the blood coagulation mechanism of, and immune response to, factor VIII with a combination of structural and biochemical techniques can lead to improved therapies for hemophilia A patients.